Radiochemical, Microbiological and Chemical Testing for Food Defense, Method Development and Building Capabilities.

PROJECT SUMMARY
(Overall):
The overarching goal of this proposal is to leverage the Wadsworth Center’s considerable laboratory capabilities
and capacity as a world-class public health laboratory and research institute, coupled with its scientific expertise
to maintain a first-class integrated program for Radiochemical, Microbiological and Chemical Testing for
Food Defense, Method Development and Building Capabilities that will serve the needs of the FDA’s Food
Emergency Response Network (FERN). Building on its current success as an FDA-FERN Cooperative
Agreement laboratory supporting Radiochemical, Microbiological and Chemical Food Defense activities, and as
a USDA Food Safety Inspection Service (FSIS) Cooperative Agreement laboratory for Microbiology and
Chemistry Food Defense, the Wadsworth Center will continue to provide key leadership, scientific expertise and
analytical support to FERN under the next cycle of the Laboratory Flexible Funding Model (LFFM). Wadsworth
is the laboratory of last resort that NY state government agencies turn to for help with microbiology, biodefense,
radiochemistry and nuclear counting technologies, and chemical testing for emergency response and
preparedness based on access to state-of-the-art mass spectrometry expertise. The scope of this proposal
includes Microbiology Food Defense; Sequencing of isolates in the Wadsworth Center’s core sequencing facility,
and the sequence and metadata uploaded to the GenomeTrakr umbrella project at NCBI; Chemistry Food
Defense for organic and inorganic toxic chemicals; and Radiological Food Defense for screening and
quantification of a, b, and g emitters in food products.

Public health relevance
PROJECT NARRATIVE The overarching goal of this proposal leverages the Wadsworth Center’s considerable laboratory capabilities and capacity as a world-class public health laboratory and research institute, coupled with its scientific expertise to maintain the Radiochemical, Microbiological and Chemical Testing for Food Defense, Method Development and Building Capabilities program. This program will serve the needs of the FDA’s Food Emergency Response Network (FERN), by building on its current success as an FDA-FERN Laboratory Flexible Funding Model (LFFM) Cooperative Agreement laboratory. As the laboratory of last resort that NY state government agencies turn to for help, Wadswoth maintains expertise in microbiology, biodefense, radiochemistry and nuclear counting technologies, and chemical testing for emergency response and preparedness based on access to state-of-the-art mass spectrometry.